Locomotor Training with Anabolic Adjuvants for Musculoskeletal Recovery After SCI

Muscle and bone loss are hallmark consequences of spinal cord injury (SCI) that impede physical rehabilitation
and worsen health outcomes. This musculoskeletal decline is precipitated by disuse resulting from the
neurologic insult and is intensified by other factors, including impaired insulin-like growth factor (IGF)-1
signaling in muscle and bone. The presence of multifactorial impairments likely underlies the relative
ineffectiveness of most stand-alone pharmacologic and mechanical reloading strategies in regenerating both
bone and muscle after severe SCI. Our goal is to establish a multimodal strategy combining physical
rehabilitation with adjuvant IGF-1 to promote musculoskeletal recovery after SCI, thus addressing both the
disuse and the impaired anabolic signaling. Our data indicate that passive Cycle training and bodyweight
supported treadmill (TM) training, forms of activity-based physical rehabilitation, reduce muscle loss and
promote neuroplasticity in rodents after moderate contusion SCI. However, these physical rehabilitation
regimens are relatively ineffective in regenerating muscle and bone after severe SCI. IGF-1 is known to
independently influence musculoskeletal integrity, suggesting this anabolic may represent a viable candidate to
improve physical rehabilitation after SCI. Indeed, our data indicate that viral overexpression of IGF-1 in muscle
protects muscle during disuse and promotes muscle and bone recovery upon reloading. Additionally, viral IGF-
1 expression has been shown to promote corticospinal motor neuron survival after spinal cord transection, an
effect essential to the preservation of muscle function after SCI. However, viral IGF-1 therapies are not highly
translational. To address this, we developed a novel orally-bioavailable human IGF-1 expressed in edible
plants (Plant-Pro-IGF-1) and optimized a dosing regimen in rats and mice that increases circulating IGF-1 by
300-500% for at least 12 h, without suppressing circulating glucose. We have also demonstrated that Plant-
Pro-IGF-1 reaches skeletal muscle, the primary target tissue, and that Plant-Pro-IGF-1 phosphorylates IGFR
and Akt in time and dose-dependent manners in cultured cells, validating bioactivity. For this proposal, we will
evaluate Plant-Pro-IGF-1 alone and in combination with activity-based physical rehabilitation in our rodent
severe contusion SCI model, which represents the next step in translating this highly novel compound to
clinical trials in the SCI population. All studies will be conducted in 4-month old male and female Sprague-
Dawley rats receiving Sham surgery vs severe mid-thoracic (T9) contusion SCI. We will perform experiments
using immediate and delayed treatment strategies to determine preventative and regenerative efficacy,
respectively, which provides insight into the most appropriate treatment window. We will also assess the
influence of passive (Cycle) vs dynamic (TM) loading on IGF-1 efficacy and we will evaluate forelimb and
hindlimb musculoskeletal outcomes to determine if therapeutic efficacy requires normal innervation or
unimpaired locomotor activity, factors that are only present in forelimbs after severe T9 SCI. Outcomes include:
muscle cross sectional area (via MRI), muscle morphology (via immunohistochemistry), isolated muscle
mechanics, muscle IGF-1 signaling, bone volume (via microCT), bone turnover (via histomorphometry and
circulating markers), soleus corticospinal motor neuron morphology/distribution, and serum IGF-1, IGF binding
protein 3, and glucose. This proposal has two Specific Aims:
Aim 1. Evaluate the ability of administered IGF-1 to enhance the acute musculoskeletal effects of
activity-based physical rehabilitation in a rodent contusion SCI model.
Aim 2. Determine if a multimodal therapy combining activity-based physical rehabilitation with
adjuvant IGF-1 regenerates bone and muscle when administered chronically after severe SCI.

Public health relevance
More than 42,000 individuals with spinal cord injury (SCI) are eligible for treatment in the VA Healthcare System, with direct healthcare expenditures exceeding $716 million/year. Severe muscle and bone deficits are hallmark consequences of functionally-complete SCI that worsen metabolic co-morbidities, increase bone fracture risk, and impede successful physical rehabilitation. No stand-alone pharmacologic or mechanical reloading strategy simultaneously regenerates muscle and bone after SCI. As such, significant need exists to identify novel therapeutic strategies that can be used in conjunction with physical rehabilitation to promote musculoskeletal recovery after SCI.